Administrative Core

The Administration Core will be responsible for the overall management of the MNORC, its Cores and the Weight Management Programs. The MNORC will continue to set goals and objectives for the Center's operation and conduct ongoing review of the Center through consultation and survey of the Center's membership, advice of Internal and External Advisory Committees and interactions with other P30 and external NORCs. The Administration Core will oversee the resource expenditures of the MNORC and be responsible for the reporting to internal and external stakeholders and to the NIH. The MNORC Administration Core, through the Core's Working Group, will oversee all Enrichment Programs and the Pilot and Feasibility Grant Programs, ensuring that expenditure of cost-share funds are properly allocated to support investigators. The Core will also ensure that agreements between the administrations of entities who have agreed to co-funding will be properly executed and documented. The Administration Core will maintain a Website for investigators and the public use to interact and to promote MNORC activities. Finally, the Administration Core will be the conduit for the interactions of the MNORC with the research community at the University of Michigan and be responsive to the needs of the community, especially the Research Base. It will be the responsibility of the Administration Core to encourage researchers to become new members of the MNORC Research Base and to encourage interactions between the research community.